Improving mRNA vaccines with extracellular vesicle-associated immunogens

Abstract
The central hypothesis of this proposal is that the efficacy of mRNA vaccines that deliver membrane-anchored
immunogens can be improved by localizing the immunogen to extracellular vesicles (EVs, small membrane-
limited structures shed by eukaryotic cells). Our rationale is that EVs provide a natural scaffold for immunogen
multimerization while also enabling membrane-bound antigens to access antigen presenting cells, both local to
the site of injection, and in the draining lymph node.
To localize immunogens to EVs and promote EV shedding we propose two complimentary approaches. In Aim
1, we will append a viral “late domain” to the carboxy terminus of our immunogen. Viral late domains are small
protein domains, usually associated with a matrix or capsid protein, used by enveloped viruses to facilitate
budding and egress. We have found that these domains can act out of context; fusing a late domain from
feline immunodeficiency virus Gag to a SARS-CoV-2 spike protein immunogen caused the immunogen to re-
localize to EVs and improved its immunogenicity nearly two-fold. We will expand this work by testing late
domains from other viruses for their ability to promote EV localization and/or production. We will thoroughly
characterize these EVs to determine correlates of vaccine immunogenicity.
In Aim 2, we will modify our immunogens to overcome the activity of the host anti-viral restriction factor BST-2
(a.k.a. tetherin). Tetherin inhibits viral egress by “tethering” budding enveloped viruses to the host cell
membranes and also inhibits the release of EVs by the same mechanism. Therefore, we will explore
strategies for antagonizing tetherin in order to promote release of our immunogen-laden EVs. Enveloped
viruses have evolved different strategies for tetherin evasion that we will attempt to incorporate into our
immunogen designs. Indeed, we have identified a portion of the SARS-CoV-2 spike protein that we suspect is
responsible for tetherin antagonism. Incorporating this S protein domain into our immunogen dramatically
increases the amount of immunogen recovered from EV fractions of tissue culture supernatants. We will also
explore similar strategies based on tetherin resistance mechanisms from other viruses.
Finally, in Aim 3, promising immunogen design strategies in the context of different viral envelope protein
immunogens (SARS-CoV-2, influenza A virus, HIV) will be compared in mice. These tests will allow us to
establish correlations between the behavior of our vaccine immunogens in tissue culture (quantity and
characteristics of the EVs, cytoxicity, etc.) and performance of the vaccine in vivo and determine if our
modifications universally improve vaccine efficacy, or if particular immunogen designs are better suited for
specific viral antigens.

Public health relevance
Project Narrative The success of the mRNA vaccine platform in the context of COVID19 has sparked interest in its use for other viral diseases. Here we propose a general strategy for improving mRNA vaccines that enables the mRNA-encoded proteins assemble into more natural virus-like structures. These modifications will empower mRNA vaccines to raise better, longer-lasting antibody responses while reducing the amount of mRNA required in each dose.